Obesity Health Disparities Research Center (OHDRC)

Abstract
The Obesity Health Disparities Research Center (OHDRC), led by the University of Alabama at Birmingham
(UAB) in partnership with Louisiana State University (LSU), the University of Mississippi Medical Center
(UMMC) and Jackson State University (JSU), focuses on the theme of obesity and obesity-related health
disparities across the life course. The purpose of this Administrative Supplement is to provide bridge funding to
continue key OHDRC activities toward the overall goal of reducing the disparities in obesity between African
Americans and Whites, thereby reducing related health disparities in prevalent chronic diseases. To achieve
this goal, we support transdisciplinary, multi-level, multi-domain research on obesity-related health disparities
to understand the complex contributors to obesity and how they vary at critical periods across the life course.
Having started with the State of Alabama in 2018 and expanding to Mississippi and Louisiana in 2019, the
OHDRC focuses on African Americans living in rural and low-income inner-city communities across the
Southeast. With this supplement the OHDRC can maintain the infrastructure, partnerships, and resources that
have been critical to our success. Specifically, we will 1) maintain the OHDRC infrastructure and staff to
support the work of the OHDRC and our partners; 2) continue investigator development through another class
of up to 6 participants in the Obesity Health Disparities Research Education Program, 4) continue the
evaluation activities of the OHDRC, 5) continue our obesity intervention initiatives, Healthy Happy Kids and the
Building Healthy Communities Coalitions, 6) finalize and disseminate a special issue of the American Journal
of Preventive Medicine, 7) hold a Research Symposium in Fall 20022 and a Close-Out Community Partner
Summit in Spring 2023, to disseminate findings and share best practices, 8) fund and support 1 additional Pilot
and 2 additional Secondary Data Analysis grants, and 9) complete our research projects by finalizing data
collection and analysis and completing the Common Data Elements Social Determinants of Health (SDH)
Resource to incorporate additional area-level measures and link to electronic health records data.

Public health relevance
Narrative The Obesity Health Disparities Research Center (OHDRC), led by the University of Alabama at Birmingham (UAB) in partnership with Louisiana State University (LSU), the University of Mississippi Medical Center (UMMC) and Jackson State University (JSU), focuses on the theme of obesity and obesity-related health disparities across the life course, toward the overall goal of reducing the disparities in obesity between African Americans and Whites, thereby reducing related health disparities in prevalent chronic diseases. The purpose of this Administrative Supplement is to provide continuation funding for key OHDRC activities. This supplement will allow the OHDRC to maintain the supporting staff, partnerships, and infrastructure necessary to exert a sustained, powerful influence on health disparities research in the Southeast and across the United States.